A universal pipeline for functional characterization of the human microbiota at a massive scale

Project Summary
The community of microorganisms within our gastrointestinal tract, collectively known as the gut microbiota,
constitutes one of the densest and most diverse bacterial ecosystems known. While the close relationship
between humans and their microbiota represents vast potential for engineering human health, we are currently
limited in tools required to unravel the intrinsic complexity. Our ability to predictably harness the microbiota for
beneficial health outcomes requires a fundamental understanding of the physiology of these bacteria, yet most
human gut bacteria have never been studied using molecular genetic tools and are too distantly related from
well-studied model bacteria to accurately transfer gene annotations by homology. This major gap in our
functional understanding of gene functions in human gut bacteria must be addressed with systematic efforts,
which will require multiple complementary expertise.
High-throughput genetics is an attractive approach for characterizing the biological functions of genes
within the human microbiota. Application of perturbations en masse to large populations of genetically modified
bacteria permits the parallel assessment of nearly all genes. A similar high-throughput strategy can potentially
be applied to the human gut microbiome, but there are multiple major obstacles that we aim to resolve in this
project: (1) transformation of non-model bacteria remains challenging and is a largely trial-by-error effort, (2)
the development of a new genetic system for a non-model bacterium is time-consuming, (3) the adoption of
multiple technologies and laboratory workflows complicates the comparison of data across teams, (4) in vivo
mouse experiments should ideally be carried out in ex-germ-free mice colonized by mutants of interest.
The team assembled for this grant includes leaders at the forefront of novel cultivation methods,
electroporation for genetic transformation, and tools for assessing gene function in vitro and in vivo. In Aim 1,
we will rapidly develop genetic tools for a large number of human gut commensal strains, with the ultimate goal
of generating genome-wide randomly barcoded transposon mutant libraries for sequencing. We will utilize
these libraries to test the phenotypic importance of all non-essential genes across a multitude of in vitro (Aim 2)
and in vivo (Aim 3) conditions to globally discover new gene functions. Through our combined expertise in
bacteriology, microfluidics, high-throughput screening, host-microbe interactions, and imaging, we will produce
genetic tools and fitness data for the vast community of microbiota researchers at unprecedented scale, and
deliver deep insight into the physiology of the human gut microbiota.

Public health relevance
Project Narrative Our ability to predictably harness the microbiota for beneficial health outcomes requires a fundamental understanding of the physiology of these bacteria, yet most human gut bacteria have never been studied using molecular genetic tools. In this proposal, we aim to address this major gap in our functional understanding of gene functions in human gut bacteria through systematic efforts to optimize transformation efficiency, construct barcoded transposon-insertion libraries, and map gene-phenotype relationships in vitro and in vivo.